PET Imaging of alpha 7 and alpha4beta2-nAChR in Schizophrenia: Cognitive Relationships

This is a competitive renewal of an R01 that initially was funded on validation of the first positron emission
tomography (PET) radiotracer, [18F] ASEM, which binds specifically to α7 subtype of nicotinic acetylcholine
receptors (α7-nAChR) successfully in human studies. Our development and validation of [18F] ASEM in our prior
funding period was critical for future and in the current application we proposed in vivo investigation of α7-nAChR
in schizophrenia (SCZ), and cognitive function. Deficits in cognitive function are a core feature of SCZ. People
with SCZ show marked deficits in attention, working and long-term memory, and executive functioning. A strong
association between low α7-nAChR density and severity of cognitive deficits has been demonstrated in animal
models, and with SCZ diagnosis in human post-mortem studies. The overarching goal of the current proposal is
to determine α7-nAChR availability in SCZ in vivo in connection with cognitive deficits. In the prior funding period,
we established age effects, excellent test/retest reproducibility, and specificity of binding of [18F] ASEM to α7-
nAChR. In this renewal, we propose to enroll 60 patients with SCZ and 60 controls matched for smoking status,
age, sex, race, and parental socioeconomic status. Subjects will be genotyped for a SCZ-linked polymorphism
of α7-nAChR gene (rs3087454) which will be included as a covariate in our analysis. The majority of our planned
SCZ subject population is anticipated to be on atypical antipsychotics (AP). To anticipate possible confounds of
medication we will test the effects of 3 of the most common atypical APs of our SCZ population in baboons as a
SubAim to confirm our no-effect of atypical AP findings in mice and 1 SCZ patient on- and off-Risperidone.
Aim 1 We will test the hypothesis demonstrated in post-mortem studies and in our preliminary data, that [18F]
ASEM binding will be decreased in SCZ. Effect of AP on [18F] ASEM binding will be tested in baboons as a
SubAim1. Aim 2 Because of the high comorbidity of SCZ and tobacco use, and association between severity
of cognitive deficits in SCZ and availability of the high-affinity α4β2-nAChR subtype, we will examine in the same
SCZ and control subjects for α4β2-nAChR characteristics using our α4β2-nAChR selective PET tracer, [18F]
AZAN. Our hypothesis is that [18F] AZAN binding will be lower in the brain regions of smoking participants with
SCZ, when compared to matched smoking controls. In Aim 3 we will examine negative symptoms and cognitive
deficits using a validated cognitive battery and in clinical scales for SCZ as primary outcomes. We will determine
whether cognitive deficits are related to the α7- or the α4β2-nAChR availability, or, possibly, synergistically with
these two subtypes. This will be the first study of cognitive deficits in SCZ using two human PET tracers with
high selectivity for α7- and α4β2-nAChR. The long-term results is to determine a relationship between these two
nAChR subtypes and cognitive function in SCZ, which ultimately will provide a better understanding of nAChR
pathophysiology and guidance for future nicotinic drug development for SCZ.

Public health relevance
The objective of this R01 renewal is to quantify the α7 subtype of the nicotinic acetylcholine receptors (α7-nAChR) in subjects with schizophrenia (SCZ) using the first successful PET tracer [18F]ASEM that we characterized in healthy volunteers in the previous grant period. We will confirm for first time in vivo that α7-nAChR’s are reduced in SCZ versus healthy controls and important in relationships with cognition as has been predicted in animal models and post-mortem studies. The second objective is to compliment α7-nAChR PET studies with PET of the prevalent α4β2-nAChR that has been extensively studied in smokers and to a lesser extent in patients with SCZ of whom the majority smoke but also implicated in cognition potentially synergistically with α7-nAChR.